Keck COVID Recovery Clinic Optimal Outcomes for Patients, a Comprehensive Assessment and Management Program

SUMMARY/ABSTRACT
Post Acute Sequelae of COVID-19 (PASC) may affect 15 to 30% of people infected with
COVID-19, which would suggest at least 1 million cases in Los Angeles (LA) County and at
least 7 million cases in the United States. The COVID Recovery Clinic at Keck Medicine (Keck
CRC) of the University of Southern California (USC) was established in 2020 to treat patients
with PASC symptoms. Keck CRC operates under an interdisciplinary, collaborative care model,
and brings together a primary care physician, occupational therapist, physical therapist, social
worker, respiratory therapist, medical assistant, nurse (RN) navigator, and support coordinator.
Keck CRC is well positioned at Keck Medicine of USC and in LA County to accomplish goals to
expand and optimize clinical care of PASC, as well as to be a center for dissemination of
education and project findings across LA County and nationally across other similar clinics.
Through this funding opportunity, the Keck CRC will establish the Keck COVID Recovery Clinic,
Optimal Outcomes for Patients in a Comprehensive Assessment and Management Program
(Keck CO-OP CAMP). This program will pursue four main goals, in alignment with the eight
characteristics of Long COVID clinics specified in the Funding Opportunity “Purpose of the
NOFO” (RFA-HS-23-012):
Goal 1: Improve current care delivery and system model within Keck CRC (NOFO 1, 2, 3,
4). Activities under this goal will optimize and update the current Keck CRC care model through
expanding dedicated staff time and roles, creating and adapting clinical workflows, improving
care coordination, establishing mechanisms for oversight, and utilizing data collection and
analysis.
Goal 2: Establish new models of service to expand services to more patients
experiencing PASC, including those who may be limited from ongoing care through the
clinic due to insurance or geographic limitations (NOFO 1, 2, 3, 5). Activities under this goal
will include creating additional consultation services in-person and virtually, connecting with
clinics that may benefit from our resources, adding a support group, and educating patients,
caregivers, and healthcare workers.
Goal 3: Create multidisciplinary education resources for internal and external providers
(NOFO 5, 6, 8). Activities under this goal will include creating clinical workflows, educational
materials, and resources, and connecting with clinics that may benefit from Keck CRC
resources.
Goal 4: Implement consistent and standardized data collection on patient and clinic
outcomes, with regular periodic assessment of data, to inform ongoing modifications in
care delivery. (NOFO 7, 8). Activities under this goal will include utilizing and adapting
technology for data collection, assessment of data, interpretation of data, and dissemination of
findings.

Public health relevance
NARRATIVE The COVID Recovery Clinic at Keck Medicine (Keck CRC) of the University of Southern California (USC) has treated patients with Long COVID since 2020. In this proposal, Keck CRC will improve its current care delivery and symptom model, establish new models of service to expand services to more patients, create multidisciplinary education resources for healthcare providers, and collect and analyze standardized data on patient and clinic outcomes to inform ongoing modifications in care delivery.